Clinical Validation of Metabolic Markers Detected by Mass Spectrometry Imaging for Diagnosis of Thyroid Fine Needle Aspiration Biopsies

Accurate diagnosis of thyroid nodules by fine needle aspirate (FNA) biopsy is essential to modern day best
practice care in patients who are at risk of thyroid cancer. Current diagnosis of suspicious thyroid nodules relies
on the interpretation of cytology findings by cytopathology. Unfortunately, difficulties in FNA diagnosis due to
overlapping cytological features, inadequate sample size, or lack of clear pattern result in an indeterminate
diagnosis in ~ 20% of cases. Clinical guidelines recommend that patients with indeterminate FNA undergo further
testing including repeat biopsy (painful, may yield same indeterminate result), genomic analysis (expensive, not
always available), or diagnostic thyroid surgery (very expensive, painful, invasive, with many life altering
complications). Shockingly, 70-90% of patients that undergo diagnostic surgery are found to present benign
nodules by surgical pathology, meaning that surgery was completely unnecessary. Unnecessary surgeries have
major negative consequences. For patients, diagnostic surgery hypothyroidism results in decreased quality of
life and lifelong need for hormone replacement therapy. For the healthcare system, the cost from unnecessary
surgeries is enormous. Despite best efforts in genomic analysis and improved cytologic classification, there still
remains a large diagnostic gap and need for improved technology for preoperative diagnosis of thyroid cancers.
To address this critical clinical need, we have combined our expertise in thyroid cancer/surgery (Dr.
James Suliburk, Department of Surgery, Baylor College of Medicine, BCM), mass spectrometry imaging (Dr.
Livia S. Eberlin, Department of Chemistry, The University of Texas at Austin), statistical analysis (Dr. Rob
Tibshirani, Department of Biomedical Data Science, Stanford University), clinical chemistry (Dr. Rongrong
Huang, Scientific Director of Clinical Chemistry, BCM), and clinical pathology (Dr. Thomas Wheeler, Department
of Pathology, BCM), and developed an assay using mass spectrometry imaging and machine learning to
diagnose FNA biopsies based on the detection of a profile of hundreds of metabolic markers directly from clinical
specimens. Now, we propose to conduct critical analytical and clinical validation studies with FNA biopsies
prospectively collected from patients undergoing treatment at BCM to rigorously validate the method for clinical
implementation. During the UH2 research phase, we will establish key analytical performance metrics, quality
control measures, and method standardization procedures to evaluate the performance of our assay and
metabolic markers within its clinical context of use. During the UH3 research phase, we will validate the clinical
and diagnostic performance for FNA diagnosis in comparison to gold standard pathologic evaluation. Our
premise is that the rigorous studies proposed will complete the analytical and clinical tasks needed to validate
our assay and predictive markers for thyroid FNA diagnosis, thus demonstrating its effectiveness as a diagnostic
assay. With support from commercial partners, our ultimate objective is to develop this innovative metabolic test
into a robust technology for high-throughput and accurate diagnosis of thyroid FNA material.

Public health relevance
Diagnosis of a fine needle aspiration (FNA) biopsies obtained from patients with a suspicious thyroid nodules can be extremely challenging using standard clinical pathology workflows. The majority of patients that receive an indeterminate biopsy result undergo a diagnostic surgery to later find out that the surgical procedure was completely unnecessary, leading to life-altering side effects. Here, we propose to conduct a large validation study to evaluate the analytical and clinical performance of a new molecular test we have developed to diagnose FNA biopsies based on the detection of hundreds of metabolic markers, with the expectation to improve diagnosis and thus reduce the number of unnecessary diagnostic thyroid surgeries for patients.